Save Kidneys in Cisplatin Chemotherapy by blocking HDAC6

Project Summary
Cisplatin and its derivatives are the most widely used chemotherapeutic agents for treating solid tumors.
However, cisplatin induces kidney injury during its use in cancer therapy. Currently, no treatment is available for
cisplatin-induced kidney injury except supportive care. The goal of this project is to elucidate the role and
mechanism of histone deacetylase 6 (HDAC6) in cisplatin-induced kidney injury, fibrosis and chronic kidney
disease (CKD), and to identify HDAC6 inhibition as a novel approach for renoprotection during cancer treatment.
In our preliminary studies, HDAC6 was up-regulated in acute kidney injury (AKI) induced by a single high-dose of
cisplatin in mice and pharmacological inhibition of HDAC6 attenuated renal tubular apoptosis and AKI. HDAC6
was also highly induced by repeated low-dose cisplatin (RLDC) treatment, which was accompanied by renal
interstitial fibrosis, persistent activation of epidermal growth factor receptor (EGFR) and autophagy, and
deacetylation of α-tubulin, a key process in cilium disassembly. Importantly, pharmacological and genetic
blockade of HDAC6 reduced RLDC-induced renal fibrosis. Moreover, cisplatin treatment induced shortening of
primary cilium in cultured renal epithelial cells, and the cells with shorter cilia were more sensitive to
cisplatin-induced injury. These data, together with a known cancer-promoting role of HDAC6 in tumors, have led
to our hypothesis that blockade of HDAC6 may protect kidneys during cisplatin chemotherapy while enhancing
its anti-cancer efficacy in tumors. Mechanistically, HDAC6 may contribute to the development of chronic kidney
problems after cisplatin treatment through the activation of EGFR and autophagy, and disassembly of primary
cilium in renal tubular cells. We propose three specific aims to (1) test the hypothesis that HDAC6 can protect
kidneys during cisplatin treatment while enhancing the chemotherapy effects in tumors; (2) test the hypothesis
that HDAC6 contributes to cisplatin-induced renal injury, fibrosis and CKD by persistent activation of EGFR and
autophagy; and (3) test the hypothesis that HDAC6-mediated ciliary disassembly aggravates kidney injury,
fibrosis and CKD following cisplatin treatment. Successful completion of the proposed studies will define the
therapeutic effect of HDAC6 inhibition on cisplatin-induced renal damage and fibrosis, elucidate the underlying
mechanisms, and identify a novel strategy for kidney protection while enhancing chemotherapeutic efficacy.

Public health relevance
Project Narrative Cisplatin is the most widely used chemotherapeutic agent for treating solid tumors, but it can cause acute and chronic kidney injury. This application will investigate the role and mechanism of histone deacetylase 6 in cisplatin-induced renal damage and explore a novel strategy for kidney protection while enhancing chemotherapeutic efficacy.